CHARACTERIZATION OF RECEPTOR LIGAND INTERACTIONS RELEVANT TO HIV INFECTION

Summary of Work: Infection by the HIV virus causes a change in a number of physiological processes, the etiologies of which are poorly understood. The initial step is syncitium formation, currently accepted as involving HIV gp120 and gp41, CD4 and chemokine a receptor. Later developments include the depletion of T cells expressing CD4 and B cells expressing immunoglobulins, and changes in the regulation of cytokines. Crucial to an understanding of these processes and to developing therapeutic strategies related to these changes is the determination of the structural motifs critical to the physiological processes involved in the changes. We are employing the methodologies we have been using for epitope determination (protection assays and surface modification reactions combined with mass spectrometry) to probe receptor-ligand pairs relevant to HIV infection including: a) CD4 and gp120 and; b) the complex between gp120, CD4 and chemokine receptor CXCR4. The ternary complex between gp120, CD4 and a chemokine receptor is now accepted as the crucial interaction involved in cellular infection by the HIV. Identification of the sites of interaction on any or all of the molecules involved in the complex will provide information that should be useful in design of vaccines and/or drugs that inhibit infection. Our initial experiments have been to probe uncomplexed gp120 in solution using a variety of enzymes to characterize the digestion products. Included in this part of the project is the determination of the the glycosylation pattern of gp120. Dr. Edward Berger, (NIAID) has agreed to provide us with his vaccinia virus expression system for CXCR4. The expression will be carried out at NIEHS in collaboration with Drs. Charles Romeo/David Armstrong (LST/NIEHS). Because CXCR4 is a membrane- bound protein, and the relevant interactions occur with CXCR4 membrane- bound, the receptor will be prepared in liposomes. Drs. Aaron Xu and Robert London (LSB/NIEHS) have agreed to collaborate with us on this part of the project.